Raise Awareness In Students Early (RAISE) in Oral Biology Program

PROJECT SUMMARY
The primary objective of the Raise Awareness In Students Early (RAISE) in Oral Biology Program is to
provide short-term research experiences and training for talented undergraduate students in the area of oral
biology. The Medical University of South Carolina (MUSC) RAISE Program will 1) recruit and engage
undergraduate students who demonstrate ambition and determination to pursue an oral biology-related career;
2) provide the knowledge and skills that will prepare students for advanced degree admission and a biomedical
career in oral biology, and 3) enhance the research workforce by nurturing the academic and professional growth
of students that represent all aspects of race, ethnicity, socioeconomic status, and life experiences. The 10-
week program will recruit nine students per year. Special consideration will be given to students from
economically and/or socially disadvantaged backgrounds, including underrepresented minority applicants, first-
generation students, and students from non-research-intensive South Carolina higher education institutions.
Students will conduct a biomedical hypothesis-driven project under the guidance of a faculty mentor whose
research program is aligned with the National Institute of Dental and Craniofacial Research (NIDCR) scientific
priorities. The program will leverage the expertise of MUSC faculty, many of whom are established mentors on
our NIDCR T32 Training in Craniofacial and Oral Health Research (T-COHR) grant. Dr. Yilmaz, DDS, PhD
and Dr. Westwater, PhD with their complementary backgrounds in academic mentoring bring forth a successfully
integrated undergraduate oral biology program encompassing basic science, clinical knowledge, and
team-based leadership. In addition to hands-on research training in oral biology, students will receive
responsible conduct of research training, professional development, and networking opportunities. Activities will
include an authentic research experience; a specialized lecture series; formal and informal discussions on the
core principles of rigor and reproducibility; and a journal club focused on the connection between oral health and
systemic conditions. Trainees will gain an appreciation for the translational relevance of their studies through
interprofessional experiences in a clinical setting. The program will culminate with formal presentation at the
MUSC Summer Undergraduate Research Symposium, a one-day conference in which students present their
research to their peers, primary mentors, and research team advisors. Students will be encouraged to build both
social and academic networks. Each student will be paired via the Big Sister/Brother Program with a student,
who will provide professional and social support while on the MUSC campus. After graduating from the RAISE
Program, students will be enrolled in the RAISE Alumni Network. Inclusion in this network will facilitate post-
program career planning and will increase the likelihood that students will select long-term careers in oral biology-
related fields. In turn, we expect our alumni to become part of the research workforce who will focus on improving
oral health and well-being for all individuals across the lifespan.

Public health relevance
PUBLIC HEALTH RELEVANCE STATEMENT There is an urgent need to increase the number of scientists from diverse backgrounds who are committed to the study of oral biology and its relation to overall health. The MUSC RAISE program seeks to overcome barriers that have prevented or hindered undergraduate students from gaining experiences that would engage and inspire students to continue their professional careers in the field of oral biology. The ultimate goal of the RAISE program is to foster the development of a cadre of diverse scientists who will become part of the scientific workforce dedicated to improving oral health and overall health for all.